EFFECT OF PROSTAGLANDIN E1 ON HUMAN PANCREAS ALLOGRAFT POST TRANSPLANTATION

Evaluate the effect of PG1 on the endocrine function of the human whole-organ pancreas allograft in the early post-transplant period.